ADMINISTRATION AT TEXAS SOUTHERN RCMI

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The administrative component of the Institute is organized to ensure a unified thrust toward the attainment of the goals and objectives of the Institute by improving the research infrastructure and properly managing the day-to-day operations of the program. The administrative component is responsible for implementing policies and procedures as determined by the National RCMI Advisory Committee (NRAC);performing day-to-day management and operations of the program;improving and supporting the research infrastructure, including timely procurement of equipment and research supplies and facilities maintenance;supporting investigators;helping to develop new research projects;assisting in procurement of research materials and services needed to conduct research;maintaining budgets and preparing reports;providing clerical support for the program;providing animal care support for research;and providing oversight for the student development program.